Targeting Na,K-ATPase alpha4 for male contraception

PROJECT SUMMARY / ABSTRACT
The rapidly growing world population and the high rate of unintended pregnancies make contraception a
need and a priority for any public health program. While several contraceptive methods, with varying efficacy
are currently available for women, a more comprehensive approach to birth control requires extending
contraception to males. However, a safe, effective and reversible contraceptive for men is still unavailable. An
attractive approach to develop male contraceptives consists in targeting proteins that are specifically
expressed in sperm and are required for sperm fertility. We have shown that Na,K-ATPase α4 (NKAα4), a
plasma membrane ion transporter which exchanges cytoplasmic Na+ for extracellular K+, is a validated target
for male contraception. NKAα4 is uniquely expressed in testis male germ cells after meiosis, is particularly
abundant in the sperm flagellum, and is critical for sperm function. Deletion of NAKα4 in mice results in
complete sterility of only the male but not the female animals. NKAα4 is essential for sperm motility and sperm
capacitation. Its activity maintains sperm intracellular Na+ levels ([Na+]i) and several vital sperm parameters,
including membrane potential (Vm), intracellular Ca+2 ([Ca2+]i) and pH. From a biochemical standpoint, NKAα4
has a particularly high affinity for ouabain, the specific inhibitor of Na,K-ATPase. We took advantage of this
property to specifically target NKAα4 and block its function to achieve male infertility. We synthesized a series
of small molecule compounds, which can selectively bind to the high ouabain affinity site of NKAα4. Some of
these compounds inhibit NKAα4 and affect sperm motility both in vitro and after administration to mice. This
provides strong evidence for the suitability of NKAα4 as a pharmacological target and our compounds as
agents that can be used for the control of male fertility. However, before NKAα4 inhibitors can be moved
forward into their application as male contraceptives, it is necessary that their efficacy, drug-target interaction,
biomarkers for their in vitro and vivo specificity, side effects, mechanisms of action and pharmacokinetic
parameters are identified and optimized for future clinical use. We will test this in two aims. In specific aim 1,
we will develop compounds with the capacity to selectively inhibit NKAα4 and block sperm function, which will
be ready for testing in mice. Then, during specific aim 2, we will perform studies to obtain preclinical validation
to advance the NKAα4 inhibitors as male contraceptives. A series of rigorous approaches from the medicinal
chemistry and biological areas will be used to identify the compounds which will have the characteristics that
will be necessary for male contraception. This research will be essential to fulfill the highly desired unmet goal
of obtaining a non-hormonal pharmacological agent that could be used as an oral, reversible agent for the
control of male fertility.

Public health relevance
NARRATIVE The present proposal is directed to develop a non-hormonal agent that could be used as an oral and reversible contraceptive for males. The goals of the project are: 1) to develop a lead and a backup compound that can selectively inhibit the sperm specific NKAα4 to block sperm function, and that will be ready for testing on mice; and 2) to perform preclinical investigational new drug (IND)-enabling studies, which will allow moving these compounds forward for their use as male contraceptives.